2015 ASN Advances in Research Conference

? DESCRIPTION (provided by applicant): The annual meeting of the American Society of Nephrology (ASN) is the largest gathering in the world of clinical and basic scientists working on the kidney. During the first two days of Kidney Week, the ASN sponsors a series of intensive symposia including a two-day Advances in Research symposium for clinician investigators, graduate students, postdoctoral fellows, early- to mid-career academicians, practicing physicians and allied health care professionals. The subject area of this symposium is reviewed thoroughly by the ASN's Post-Graduate Education (PGE) Committee and reflects important and time-sensitive areas of clinical and translational investigation with important clinical and public health implications for the management of kidney diseases and their related comorbidities and complications. The 2015 ASN Advances in Research Conference entitled, Advances in Research Conference: Engineering Genomes to Model Disease, Target Mutations and Personalize Therapy, scheduled for November 3-4, 2015 in San Diego, CA. The conference will explore concepts, innovations and best practices in genome modification as it relates to the kidney in both health and disease. The purpose of this grant application is to request funds for postdoctoral fellow and graduate student travel awards so that ASN members at early stages of their careers can attend this conference prior to the 2015 ASN annual meeting in San Diego, CA.

Public health relevance
PUBLIC HEALTH RELEVANCE This conference focuses on exploring concepts, innovations, and best practices in genome editing as it relates to the kidney. Over two days, the expert faculty address both the development of novel models of kidney disease and new therapeutic approaches for humans with kidney disease using gene editing techniques. A full spectrum will be covered, from the basic biology of customized nucleases to clinical translation of genome engineering to applications in genetic renal disease. In the closing session, a panel of kidney experts will describe their own use of gene editing techniques across a variety of renal diseases, providing attendees with specific examples to stimulate their own research. This course brings together leading scientists, physician- scientists, clinicians, and trainees from diverse areas with common interests in using gene editing to find new treatments for kidney disease.